Estrogenicity Of Soy Formula

Genistein and daidzein are estrogenic isoflavones found in soybeans. Although they are much less potent than estradiol, infants fed soy formula have serum concentrations that are up to 4 orders of magnitude higher than estradiol. We have been in the field with a longitudinal study of infants up to 9 months old, looking in detail at the growth and development of their estrogen-responsive tissue as well as sex hormones and gonadotropins. We completed follow-up in May, 2014, and have begun data analysis. In addition, we reported this year the validation of a cytological method for asessing estrogen exposure in infants.